ECHO IDeA States Pediatric Clinical Trials Network - 2

ABSTRACT
Dartmouth is home to a robust pediatric academic program centered in the Children’s Hospital at
Dartmouth (CHaD). During the first three years of ECHO funding, we have built a highly functioning
pediatric Clinical Trials Unit and integrated it with clinical trials resources within the Dartmouth
community and the ECHO IDeA States Pediatric Clinical Trials Network (ISPCTN). This has allowed
us to support and expand the pediatric clinical trials portfolio, to recruit investigators and groups to this
core, to leverage existing resources and develop new ones, to engage local as well as multi-center
clinical trials, and to foster broad professional development. Our investigative team has contributed
substantially to the development, leadership, and protocol design and implementation of the ISPCTN.
The organization of our regional presence in the form of the Dartmouth Regional Pediatric Clinical
Trials Unit (DRP-CTU) will allow recruitment of a diverse pediatric population, including those who are
rural and underserved. Going forward, we propose to build on our existing infrastructure in support of
clinical trial implementation and professional development.
To accomplish this, we propose three Specific AIMS:
1. To develop institutional clinical research capacity targeting pregnant women and children
with a special emphasis on rural and underserved populations.
2. To foster the professional development of faculty and support team members in the
conduct of translational clinical research.
3. To stimulate and support our pediatric research community in the multicenter study of
pediatric conditions and disease processes.
We also propose a topical, impactful clinical trial to evaluate Youth Vaping Cessation Strategies,
directed by thought leaders in this field.
This initiative will provide a much-needed central coordinating platform for the conduct of pediatric
clinical trials in the Dartmouth community. It will contribute to all aspects of the ISPCTN and will
support existing and new investigators - expanding our clinical trials universe, stimulating expansion
of our portfolio, and offering new opportunities for professional development with the resultant
recruitment/training of new faculty and research staff.

Public health relevance
PROJECT NARRATIVE The Dartmouth Regional Pediatric Clinical Trials Unit provides a regional home for the conduct of interventional clinical trials for children. This Unit will support education of clinician scientists, infrastructure for the conduct of local clinical trials, and participation in the national IDeA States Pediatric Clinical Trials Network.